Providence/Boston Center for AIDS Research (CFAR)

PROJECT SUMMARY/ABSTRACT
OVERALL
The Providence/Boston Center for AIDS Research (Prov/Bos CFAR) promotes multi-disciplinary clinical,
behavioral, translational, and basic science HIV research particularly focused on marginalized populations
including men who have sex with men (MSM), people who use substances, justice-involved persons, women,
gender minorities, and at-risk youth. The CFAR has been in existence since 1998. The last cycle was a new
partnership between Lifespan/Brown University (Brown) and Boston University/Boston Medical Center
(BU/BMC) which was funded in 2017. The Prov/Bos CFAR collaborates with the Rhode Island Department of
Health, the Massachusetts Department of Public Health, and community-based organizations in both states. Our
research collaborations extend to multiple international sites (Kenya, Philippines, South Africa, Uganda, Ukraine,
and Zambia). The CFAR consists of 6 Cores (Administrative, Developmental, Clinical and Behavioral,
Biostatistics, Substance Use and Basic Science); one Scientific Working Group: HIV and Oral Health; a Diversity,
Equity, Inclusion and Belonging (DEIB) working group and the CFAR-Community Engaged Research Council
(C-CERC).
The goals of the Prov/Bos CFAR over the next five years are aligned with the NIH HIV/AIDS priorities, supporting
research to reduce the incidence of HIV and end the HIV epidemic (EHE). Specific goals of the Prov/Bos CFAR
include:
• Develop early stage HIV investigators (ESIs) both domestically and internationally.
• Among persons with HIV (PWH), address co-morbidities, co-infections and complications throughout the
life cycle.
• Develop the next generation of interventions and therapies towards HIV cure.
• Create research collaborations with communities in Rhode Island (RI) and Massachusetts (MA) and
extend what we learn in Southern New England to other high priority sites across the United States
(U.S.), including the southern U.S.—Arkansas (AR), Mississippi (MS), and Tennessee (TN)—and
globally.
The Prov/Bos CFAR has strong institutional support which had led to over a 75% increase in our funded research
base in the last cycle, hiring of 34 new faculty in HIV research, and an increase in the support for domestic and
international developmental grantees. The Prov/Bos CFAR is growing and is a dynamic consortium of
multidisciplinary innovative researchers who are working collaboratively to help end the HIV epidemic.

Public health relevance
PROJECT NARRATIVE The Providence/Boston CFAR (Prov/Bos CFAR) is a collaboration between Lifespan/Brown University and Boston University/Boston University Medical Center leveraging our complementary and synergistic strengths to build a multidisciplinary HIV research portfolio. Our CFAR is particularly focused on marginalized populations including men who have sex with men (MSM), people who use substances, justice-involved persons, women, gender minorities, and at-risk youth both domestically and globally. The resources of the CFAR have resulted in an increase in our HIV funding, increased hiring of new faculty engaged in HIV research, and support for early stage investigators to develop a career in HIV research.